Identifying mediators of sex hormone uptake and signaling

Project Summary/Abstract
Sex hormones are critical for sexual differentiation of the brain and body and diverse physiological processes
across our lifespan. In particular, sex hormone signaling in the brain has been implicated in mood and emotional
well-being, cognitive function, sexual orientation, gender identity, and libido. Many neurological and psychiatric
conditions, including depression and anxiety, PTSD, Alzheimer’s disease, multiple sclerosis, Parkinson’s
disease, ADHD, schizophrenia, and autism manifest with sex-skewed ratios or outcomes for poorly understood
reasons. These sex differences may result from dysregulated sexually dimorphic differentiation or function of
neural networks influenced by sex hormones. Despite the central importance of sex hormones in health and
disease, our understanding of how they influence cellular functions and the mechanisms by which sex hormones
modulate neural circuits to affect social behaviors remains limited. The consensus that sex hormones are small,
lipophilic bioactive agents that diffuse passively across plasma membranes has not been revisited in spite of
mounting evidence indicating the existence of facilitated uptake mechanisms for steroid hormones. In addition,
our knowledge of how sex hormones govern cellular functions via transcriptional regulation of gene expression
and rapid non-transcriptional mechanisms that engage intracellular signaling pathways is poor. Thus, an in-depth
investigation of mechanisms for sex hormone action will provide significant insights into their roles in health and
disease, and impactful biomedical applications for neurological and psychiatric conditions.
I propose to take advantage of recent technological advances and develop new tools to identify and functionally
characterize sex hormone-interacting proteins important for sex hormone uptake and signaling. I hypothesize
that many unknown tissue-specific transporters and receptors exist to mediate sex hormone action. In Aim 1, I
will employ two complementary, unbiased approaches to discover novel mediators of facilitated transport and
intracellular signaling: a CRISPR/Cas9-based genetic screen and a chemoproteomic approach using click
chemistry. In Aim 2, I will characterize candidate interacting partners identified in Aim 1 by profiling their
expression in sex hormone-responsive tissues and analyzing their function in target cells, with a focus on neural
networks that control social behaviors in mice. A comprehensive understanding of sex hormone uptake and
signaling will shed new light on the fundamental biology of these ancient bioactive molecules. Moreover, my
proposed work has the potential to discover new therapeutic targets for disorders across the fields of
endocrinology, fertility, cancer, neurology, and psychiatry.

Public health relevance
Project Narrative The prevalence and pathophysiology of many neurological and psychiatric conditions differs significantly between females and males; For example, females suffer more from mood disorders such as depression and anxiety, PTSD, Alzheimer’s disease, and multiple sclerosis, whereas Parkinson's disease, ADHD, schizophrenia, and autism disproportionately affect males. I propose to define the cellular and molecular mechanisms of sex hormone action to understand how sex hormones influence neural networks and address sex differences in health and disease. Given the diverse biological processes driven by sex hormones, my research has the potential to uncover insights relevant to the fields of neurobiology, pharmacology, endocrinology, fertility, cancer, neurology, and psychiatry, as well as to discover new therapeutic targets for disorders across these areas.